Biological and structural diversity of bacterial type IV secretion systems

The transmission of macromolecules across biological membranes is a fundamental process in all cells. In the earliest studies of genetic exchange in bacteria dating back to the 1940’s, the F plasmid (then termed ‘sex factor’) was shown to self-transfer and, through recombination, mediate transfer of the entire E. coli chromosome to recipient bacteria. In the ensuing ~80 years, studies have established the broad medical importance of F and other mobile genetic elements (MGEs) in shaping of bacterial genomes and as vectors for dissemination of antibiotic resistance and other fitness traits among bacterial populations. MGEs also encode conjugative pili or other cell surface adhesins, which promote intercellular contacts necessary for DNA transfer and establishment of robust, antibiotic-resistant biofilm communities. MGEs are transmitted intercellularly through nanomachines termed type IV secretion systems (T4SSs). The T4SSs are present in most bacterial species, where they have functionally diversified into two large subfamilies, the DNA transfer or conjugation systems and the ‘effector translocators’ that deliver effector proteins into eukaryotic host cells during infection. In our 33 years of investigations, my group has identified many mechanistic and architectural features of these nanomachines, including the first view of the translocation route for a DNA substrate through a T4SS. We have consistently implemented emerging technologies, and in this last MIRA cycle we solved structures of 4 model T4SSs in their native contexts of the bacterial cell envelope by in situ cryoelectron tomography (CryoET). We also solved a structure of a large subassembly of the F-encoded T4SS at near-atomic resolution by single-particle cryoelectron microscopy (spCryoEM). We pioneered studies of F pilus dynamics by labeling Cys-derivatized pilins with fluorescent maleimide conjugates, systematically deciphered contributions of F-encoded machine subunits to assembly of the translocation channel and F pilus, and probed functions of substrate processing factors and surface adhesins in early and late stages of substrate transfer. Moving forward, we will address three major gaps in our knowledge of these dynamic nanomachines: 1) How are substrates recruited to and delivered into and through the T4SS channel? 2) How do T4SSs elaborate conjugative pili and for what biological ends? 3) How do T4SSs promote formation and disassembly of ‘mating junctions’ and how are these junctions architecturally configured? We will continue to use powerful in vivo biochemical approaches, such as site-directed photocrosslinking, in combination with state-of-the-art super-resolution fluorescence microscopy, in situ CryoET, and spCryoEM approaches to further probe T4SS structure-function relationships. This project entails no engineering efforts that might generate strains with unforeseen biological consequences regarding human health, and all work will be compliant with relevant NIH and institutional biosafety measures. We anticipate our multidisciplinary initiatives will continue to generate important new information about the architecture, biogenesis, and mechanism of action of T4SSs.

Public health relevance
The bacterial type IV secretion systems are widely used by many medically important pathogens for transfer of mobile genetic elements that harbor genes for antibiotic resistance and for formation of antibiotic-resistant biofilms. These systems are also deployed by many pathogens to aid in infection, leading to disease. The type IV secretion systems are relevant for public health as they represent attractive targets for new therapeutics directed to blocking antibiotic resistance spread and disease progression.